MOLECULAR ANALYSIS OF MUTATIONS IN DUCHENNE AND BECKER MUSCULAR DYSTROPHY

The gene for DMD has been recently cloned. Through this study investigators hope to be able to correlate the results of a detailed mutation analysis by recombinant dna techniques with the clinical phenotype in a patient.